Clonal Therapy for Pediatric T-cell Acute Lymphoblastic Leukemia

PROJECT SUMMARY / ABSTRACT
Pediatric T-cell acute lymphoblastic leukemia (pT-ALL), with limited treatment options, has been historically
associated with inferior treatment outcomes with chemotherapy, compared to B-cell ALL. Despite the advances
made in our understanding of the etiology of pT-ALL, the overall survival of this disease has not significantly
improved. Children with recurrent T-ALL have a dismal survival rate of < 25%, and long-term survivors have an
increased burden of disease associated with the curative chemotherapies they received. Therefore, novel targeted
therapeutics in combinations are much needed. Population-based genomic and transcriptomic studies have
revealed the inter-leukemia diversity of pT-ALL. However, very little is known about intra-leukemia clonal
heterogeneity in pT-ALL that were known to contribute to drug resistance and disease recurrence. For example, it
remains mysterious what molecular and cellular features of the rare clones have to allow them to survive treatment
as other major clones are eliminated. T-ALL arises during the dynamic developmental processes and retains
hallmarks of their cellular origins. However, it remains unclear how T-cell development contributes to clonal
heterogeneity of pT-ALL. Moreover, whether cell–cell communications between cancer cells and normal cells in
the tumor microenvironment contribute to disease recurrence is unclear. Using bulk systems pharmacology and
single-cell systems biology approaches, we discovered the leukemia heterogeneity associated with T-cell
maturation and drug sensitivity in single cells. Therefore, we hypothesize that clonal therapy by targeting signaling
networks in clonal subpopulations arising from T-cell differentiation will minimize relapsed/refractory diseases and
improve outcomes for pT-ALL. Our team at St. Jude is uniquely positioned to tackle these challenges, capitalizing
on vast expertise in systems biology, ALL pharmacogenomics, and T-cell development. Specifically, in this
proposal, we will determine how T-cell development contributes to the intra-leukemia heterogeneity in pT-ALL
(Aim 1). We will map clones in pT-ALL to T-cell maturation stages by single-cell analyses of primary samples
and normal developmental T cells. We will identify clone-specific hidden drivers that drive clonal heterogeneity
and drug sensitivity. Next, we will identify drug combinations that target signaling drivers in multiple clones
(Aim 2). We will integrate bulk systems pharmacology with single-cell hidden-driver analyses to unbiasedly
predict synergistic drug combinations and validate them by drug screening. We will use patient-derived
xenografts that retain clonal complexity for in vivo validation. We will also investigate how TME reprograming
modulates clone selection with treatment in pT-ALL (Aim 3). We will reconstruct the tumor and TME
communication network from scRNA-seq data and elucidate the molecular mechanisms of clonal selection with
treatment in pT-ALL. Taken together, this project will address fundamental unanswered questions in intra-
leukemia clonality and provide a new clonal therapy approach that eliminates multiple clones, including those
that contribute to disease recurrence, thereby, improves the outcomes for children with T-ALL.

Public health relevance
PROJECT NARRATIVE Clonal heterogeneity and clonal selection contribute to drug resistance and disease recurrence in children with relapsed T-cell acute lymphoblastic leukemia (T-ALL) who have a dismal survival rate of < 25%. By single-cell approaches, we discovered the intra-leukemia heterogeneity associated with T-cell development and drug sensitivity. This project will identify clonal therapy by combining drugs that target major clones and rare ones contributing to disease relapse to improve the outcomes for children with T-ALL.